Improving the Evaluation and Management of Penicillin Allergy

Background: Reported penicillin allergies are present in 10% of the US population, with higher rates in
hospitalized and older patients; rates up to 16% have been found in VA nursing home patients. However, fewer
than 10% of patients are found to be truly allergic based on skin testing and most patients can safely receive
penicillin. The consequences of being labeled as penicillin allergic include use of broader spectrum antibiotics
which can result in more treatment failures, more adverse effects, higher healthcare costs, and increased risk
for development of antibiotic resistance. The nursing home population is particularly vulnerable to the effects of
potentially inappropriate antibiotic use due to factors including high infection burden and frailty.
Recognition of the problem of increasing antibiotic resistance and importance of antimicrobial
stewardship as a tool to curb it has heightened awareness of this issue of penicillin mis-labelling both in and
outside the VA. While guidelines for evaluating and managing penicillin allergy exist, they have been
infrequently applied in practice. This in part due to lack of provider knowledge on how to take an appropriate
penicillin, the role of allergy testing, risks of mislabeling and lack of access to specialized allergy testing.
Significance/Impact: To address these knowledge gaps, an explicit guideline-based clinical pathway and
toolkit were recently developed. These have been effectively and safely applied in selected inpatient and
outpatient settings to improve outcomes. However, they have not yet been applied to nursing home
populations. Thus, this represents a unique opportunity to apply these tools to improve penicillin antibiotic use
and outcomes in this vulnerable population.
Innovation: This project will be a pre-implementation pilot of a newly available evidence-based clinical
pathway and toolkit designed to improve evaluation and management of penicillin allergy. These were
developed and thus far only used in the non-long term care setting.
Specific Aims: 1) Identify potential barriers and facilitators to successful implementation of a clinical pathway
and toolkit aimed at improving use of penicillin in patients with documented penicillin allergies; 1a) examine
clinical staff and local leadership perspectives; 1b) examine patients and family members perspectives. 2)
Develop a modified pathway and toolkit for use in Community Living Centers (CLCs).
Methodology: This is a 1-year qualitative pilot study based at the Bedford VAMC. The Consolidated
Framework for Implementation Research (CFIR), supplemented with the Health Belief model for Aim 1b, will
guide our assessment to understand contextual factors that may affect uptake of the intervention. For Aim 1a,
we will conduct up to 15-20 in-person semi-structured interviews with CLC providers (nurses, physicians, nurse
practitioners, clinical pharmacists) and 4-6 with selected local leadership (chiefs of nursing, geriatrics, and
pharmacy, patient safety manager). We will examine factors including perceptions of risk of allergy testing,
perceived ability to successfully follow the pathway and tools, and solicit recommendations for pathway and
toolkit modifications. For Aim 1b, we will conduct up to 15-20 semi-structured interviews with CLC patients with
documented penicillin allergies and CLC residents’ family members to assess their knowledge and beliefs
including their understanding of allergy mislabeling implications and perceived susceptibility to adverse
consequences of the allergy testing strategies. Based on information from Aims 1a and 1b, we will propose
changes to the pathway and toolkit. We will establish consensus on proposed changes via input from an expert
advisory panel using a 2-round modified Delphi approach. We will then have developed a modified pathway
and toolkit for use in CLCs. Aim 1 information will also inform subsequent IIR implementation strategies.
Implementation/Next Steps: The modified clinical pathway and toolkit will be implemented at selected CLC
sites in a future IIR, with the eventual goal of scaling it up for use across the VA to improve care.

Public health relevance
Emerging antibiotic resistance is a national and global public health crisis that effects veterans and civilians alike. Inappropriate antibiotic use contributes to bacteria developing resistance to these drugs and adverse patient outcomes. The nursing home population is particularly vulnerable to the effects of inappropriate antibiotic use due to their increased susceptibility to infections, high antibiotic use, and increased susceptibility to adverse drug effects, including drug side effects and complications such as Clostridium difficile colitis. Antibiotic choice is guided in part by the patient’s allergy history, with penicillin being the most commonly reported and over-diagnosed allergy leading to unnecessary avoidance of these and related drugs with potentially negative consequences, including increased drug resistance and adverse events. The current project is a crucial first step toward improving evaluation and management of penicillin allergies of veterans in nursing home settings, thereby providing better and safer care for this vulnerable population.